AcSDKP as a novel treatment for traumatic brain injury

PROJECT SUMMARY/ABSTRACT
Traumatic brain injury (TBI) is a leading cause of long-term disability in the United States and a potential risk
factor for developing Alzheimer's Disease and Alzheimer's Disease Related Dementias (AD/ADRD). To date, no
effective therapeutic agents have been identified from TBI clinical trials. There is a compelling need to develop
novel therapeutic treatments for TBI. The objective of this project is to test and develop a tetrapeptide N-acetyl-
seryl-aspartyl-lysyl-proline (AcSDKP) as a novel treatment for TBI, and to investigate mechanisms underlying
AcSDKP treatment-enhanced functional recovery after TBI. Our data demonstrate that 3-day subcutaneous
infusion of AcSDKP initiated 1h after TBI significantly improves functional outcome in a rat contusion model of
TBI induced by controlled cortical impact (CCI) injury. Our data further show that AcSDKP not only provides
neuroprotection by reducing fibrin accumulation, lesion volume and hippocampal neuronal loss but also
promotes neurovascular remodeling including angiogenesis, synaptogenesis, and neurogenesis. These findings
indicate that AcSDKP has promise as an effective treatment for TBI. Our preliminary data demonstrate that
AcSDKP treatment significantly decreases transforming growth factor beta 1 (TGF-β1) and nuclear factor-kappa
B (NFkB) in the brain of TBI rats. Of significance, AcSDKP selectively reduces the histone deacetylase 4
(HDAC4) nuclear translocation and increases histone H3 acetylation, suggesting that HDAC4 nuclear
translocation contributes to TBI pathophysiology. Based on literature and our robust data, we will test the central
hypothesis that AcSDKP treatment improves functional recovery after TBI by reducing neuroinflammation,
enhancing neuroprotection and neurovascular remodeling by inhibiting TGF-β1/NFkB signaling, and reducing
nuclear translocation of HDAC4. To test the central hypothesis and to accomplish the objectives of this
application, we propose three Specific Aims. Aim 1 will determine the dose-response and the effective
therapeutic windows of AcSDKP for improvement of functional recovery in male and female rats after TBI. Aim
2 will determine effects of AcSDKP at optimal dose and therapeutic window on angiogenesis, neurogenesis,
axonal remodeling and neuroinflammation in male and female rats after TBI. Aim 3 will determine whether TGF-
β1/NFkB and HDAC4 nuclear translocation signaling pathways contribute to TBI pathophysiology and AcSDKP-
induced therapeutic benefits in male and female rats after TBI. Completion of this project will aid our
understanding of the mechanisms underlying AcSDKP-promotion of functional recovery after TBI. This proposal
is highly clinically relevant, and if successful will provide essential information for facilitating development of
AcSDKP as a novel therapy for TBI and have a significant impact on quality of life for TBI patients.

Public health relevance
PROJECT NARRATIVE Traumatic Brain Injury (TBI) is a major global and domestic health issue and a potential risk factor for developing Alzheimer's Disease and Alzheimer's Disease Related Dementias (AD/ADRD), and for which there are no FDA- approved effective treatments. We have found that a tetrapeptide N-acetyl-seryl-aspartyl-lysyl-proline (AcSDKP) is a novel candidate as a potential treatment for TBI. The proposed studies will elucidate the mechanisms underlying the therapeutic effects of AcSDKP and help to develop AcSDKP as an effective therapy for TBI.